Quantitative Steady-State and Dynamic Metabolic MRI for Evaluating Patients with Glioma

Project Summary
The UCSF and GE team will address the limitations of current MR metabolic imaging approaches by developing
a package of hardware and software tools to provide improved strategies for automatic prescription of imaging
sequences to reduce operator differences, provide more extensive coverage of the lesion and enable improved
serial comparisons. We will also simplify and streamline the processing and interpretation of the resulting data
by using our open source, DICOM compatible software package, SIVIC. This will include features to facilitate
the assessment of data from serial imaging examinations, as well as expanding the algorithms available to
address the analysis of more complex types of metabolic imaging data. A further critical component of the
proposal will be to refine the imaging and tissue acquisition workflow and integration of collected quantitative
biomarkers in the clinical setting.

Public health relevance
Project Narrative Outcomes of gliomas, the most common type of primary brain tumors in adults are highly infiltrative with poorly defined margins, such as time to progression vary considerably, even for patients with the same pathological grade and recent studies have indicated that more uniform outcomes are observed in sub-groups of glioma with molecular markers such as IDH, 1p19q, ATRX, p53 and MGMT. The recent development of the consensus Brain Tumor Imaging Protocol (BTIP) has reduced the variability between scans but the lack of specificity and ambiguities in interpreting changes in anatomic images remains to evaluate 1) the extent of the disease, 2) the integrity of the blood-brain-barrier (BBB), and 3) response to treatment. The integration of 1H and 13C metabolic imaging into the acquisition protocol enables a more direct assessment of the biological properties of the lesion and has been shown to improve the evaluation of changes in the spatial extent of tumor associated with response to therapy.